Uncertainty Among Patients Undergoing Lung Transplant Evaluation

ABSTRACT
As a palliative-care trained physician completing pulmonary fellowship at the University of Colorado (UC), I am
ideally positioned to conduct research focused on improving quality of life for patients with chronic lung disease
(CLD). I have already been productive in clinical research, publishing 5 abstracts, 2 first author and 8 co-
authored papers while pursuing clinical training. This NIH F32 Ruth L. Kirschstein National Research Service
Award (PA-21-048) submission will allow me to progress toward my long-term goal to improve quality of life
for patients with CLD by designing interventions to address illness uncertainty. The objective of this proposal
is to characterize illness uncertainty and illness communication among patients undergoing lung
transplant evaluation using quantitative and qualitative methodologies. I have assembled an excellent
mentorship team and the research environment at UC is ideal to complete this project. I have already obtained
funding from the Division of Pulmonary Sciences and Critical Care Medicine at UC to perform the data
collection for this proposal. Patients with CLD suffer from a high symptom burden, poor quality of life, and a
limited and uncertain prognosis. Patient perception of uncertainty (“illness uncertainty”) occurs when patients
are unable to make sense of their changing symptoms, declining functional status, and communication from
clinicians. Illness uncertainty is related to worse quality of life, depression, and anxiety in a variety of chronic
illnesses, including CLD. For patients with severe CLD, lung transplant improves quality of life and survival.
However, lung transplant evaluation is a time of distress and uncertainty. Characterizing illness uncertainty
among patients who are undergoing lung transplant evaluation is an important step in identifying factors
associated with uncertainty, and designing interventions aimed at reducing uncertainty and improving quality of
life. Patients report that better clinician communication about disease progression may decrease illness
uncertainty. How to best communicate what patients find important about how their disease will progress and
impact their lives (“illness communication”) has not been studied in CLD or among patients undergoing lung
transplant evaluation. Based on our preliminary data, we expect that patients will want information about topics
beyond an estimate of time remaining, such as progression of symptoms. The proposed study will 1)
characterize uncertainty and the illness communication patients find important using a survey of patients
undergoing lung transplant evaluation, and 2) understand how patients perceive illness uncertainty and illness
communication using semi-structured patient interviews, analyzed using a content analysis framework. The
data obtained from this proposal will inform the development of an intervention addressing illness uncertainty
and improving illness communication with patients with CLD, which will be the focus of my K23 application.

Public health relevance
PROJECT NARRATIVE I am a palliative care physician completing pulmonary fellowship who has already demonstrated potential in clinical research, publishing 5 abstracts, 2 first author, and 8 co-authored papers while pursuing clinical training. Illness uncertainty is associated with worse physical and mental well-being in a variety of chronic illnesses including chronic lung disease, and lung transplant evaluation is a particularly stressful and uncertain time for patients. The proposed study seeks to describe illness uncertainty and illness communication among patients undergoing lung transplant evaluation to inform future interventions targeting uncertainty to improve quality of life.